Convergence of Vitamin E, THC, Nicotine, Propylene Glycol and Glycerin Effects on Lung Inflammation When Vaped

PROJECT SUMMARY/ABSTRACT
Since becoming an Associate Professor two and a half years ago, I think back to my years as an Assistant
Professor and realize that my greatest moments of joy came from my mentee’s successes. Moments where they
were awarded their first grant, obtained their first faculty position and a high-impact first authored paper was
accepted all shine brightly in my memories. Equally important were the moments where a trainee came to see
me because they were feeling unsuccessful or unmotivated, and they felt they were not going to succeed in
academics, and through our conversation they arose, reassured about their good ideas, skill set and ability to
move forward in a positive and productive way. Looking forward, I worry about the amount of time committed to
administrative and clinical efforts and believe that obtaining protected time via this K24 will directly lead to
development and enrichment in three areas: 1. Mentoring, 2. Conducting cutting-edge novel research, and 3.
Learning new patient oriented research skills. I truly believe that expanding my time dedicated to mentorship will
have the greatest impact out of the three, because enhancing and supporting the training of passionate, clever,
dedicated trainees will lead to broader effects across medicine and academics relative to my research alone. In
terms of research, e-cigarettes are drug delivery (vaping) devices that entered the country in 2007 and have
exploded in terms of use, especially in adolescents and young adults whom have never smoked. We have no
longitudinal data on the health effects of vaping, particularly on lung and systemic inflammation. By leveraging
our existing cohort of young e-cigarette vapers at UCSD, the research proposed here can obtain longitudinal
data by having these subjects return at 1 and 2 years, thus giving 3 timepoints across which changes in airway
inflammation, microbiome and reactivity, and systemic inflammation can be defined. These data will help us
understand which chronic diseases will arise from chronic e-cigarette use. Asthmatics are using e-cigarettes at
a high rate, most likely because of the successful advertising campaigns tobacco companies have run,
convincing many of the lack of adverse effects of these devices. But patients with asthma have airways and
systemic inflammation, thus they are likely to be more susceptible to the pro-inflammatory and
immunomodulatory effects of vaping. By again leveraging the ongoing patient-oriented research conducted by
our team, I propose here to recruit vaping and non-vaping subjects with TH2-high allergic asthma to assess the
effects of e-cigarette aerosol inhalation on their underlying disease state. Finally, I propose to dive deeper into
clinical research design and analysis, to improve my ability to conduct high level patient oriented research and
thus yield the highest quality, relevant data possible. With the support of my own mentors (Drs. Atul Malhotra
and Victor Nizet), the support of UCSD, my existing fantastic research team and the mentees to come, I believe
the support of this K24 will make it possible to thrive as a mentor, researcher and life-long learner.

Public health relevance
PROJECT NARRATIVE Over 10% of the U.S. population is using e-cigarettes and vaping devices, with upwards of 25% of middle- schoolers and 50% of high-schoolers vaping regularly. A new generation of patient oriented researchers are needed to define and treat the health problems that will occur due to the use of these drug delivery devices. As a successful mid-career clinician, researcher and dedicated mentor, I request K24 support to protect my time such that I may expand my patient oriented research, develop my research expertise in new ways and increase my mentorship of outstanding junior investigators.